EXEMPLAR HOSPITAL INITIATION TRIAL TO ENHANCE TREATMENT ENGAGEMENT (CTN-0098). DSC5 CONTRACT. 09/20/2019 - 06/01/2024. N01DA-19-2250.

EXEMPLAR HOSPITAL INITIATION TRIAL TO ENHANCE TREATMENT ENGAGEMENT (CTN-0098).